Core-001

The overall goal of the Rockefeller Center for Clinical and Translational Science (CCTS) is to provide facilities and resources to accelerate translational science to improve human health. The Informatics Core helps achieve this goal by providing an electronic infrastructure, and educating and advising investigators on the use of bioinformatics methods and tools. Thus, its specific aims are: 1. To provide an optimal integrated Medical Informatics platform to: a) support translational research protocol development, review, implementation, and conduct, as well as management of subject and study data; b). ensure maximal inter-connectivity and adoption of data standards for sharing of data according to Informatics Domain Task Force-supported ontologies with other CTSA organizations, NIH Informatics programs, and health information exchanges; and c) provide analytical solutions and training for KL2 Clinical Scholars, other trainees, and investigators on querying Electronic Health Record data to test their hypotheses at the population level. d) develop an electronic portal for research participants to view data and to participate in protocol priority setting and design. 2. To provide an optimal Research Bioinformatics platform to: a) provide advice and consultations to investigators on experimental design, the choice of technology, and the choice of bioinformatics tools to achieve the scientific aims of their projects and how to share their data with the scientific community by depositing the results in publicly available databases; b) develop generic web-based tools to support bioinformatics analyses at Rockefeller and throughout the CTSA consortium and scientific community; c) create ontology-backed, electronic deep phenotyping systems to assist investigators world-wide in collaborating on projects and obtaining the most valuable assessments of genotype-phenotype correlations and gene-gene and geneenvironment interactions; d) conduct educational programs to enhance Translational Workforce Development in Research Bioinformatics; and e) advise investigators in extracting meaningful data from large public genomic and related databases. To accomplish these, we will: provide a secure, integrated data management system linking iRIS and other programs that is customized to benefit from Rockefeller’s focus on research and education; adopt CDE data standards for data sharing, including layered data structures following NIH best practices; insure data quality control; implement web-based applications integrating local tools with open source tools on analyzing high throughput sequencing data; create ontology-backed phenotyping platforms to facilitate genotypic correlations; assist investigators in using electronic methods to identify potential research participants; create a novel research participant portal for two-way communication with participants; educate trainees and investigators on experimental design, technologies and the choice and use of informatics tools and methods, submitting their data to public repositories, and querying public repositories, including the NYC Clinical Data Research Network. We will also adopt CTSA consortium best practices and metrics.